Mechanosensitive Channel based Pressure-Modulating Gene Therapy for Glaucoma Treatment

Glaucoma is recalcitrant to treatment and the resulting optic nerve damage is irreversible. All demographics
are susceptible to glaucoma, especially the elderly, African-Americans, Hispanics, diabetics and families with a
history of glaucoma. About three million Americans have glaucoma and the US government loses an estimated
3 billion USD each year in lost tax revenue, benefit payouts and healthcare subsidies needed to support these
citizens. There is great need for a long-lasting treatment for glaucoma, because vision loss due to glaucoma is
the second leading cause of blindness in America. The currently available pharmacological and surgical
treatments for glaucoma have significant limitations and side-effects, which include, systemic reactions to
medications, patient non-compliance, eye infections, surgical device failure, and damage to the eye. Primary
Open Angle Glaucoma (POAG) is common and is characterized by poor drainage of aqueous humor through
the conventional outflow pathway. Here, we put forth a novel commission for virally delivered Engineered
Mechanosensitive Channel (EMC) as a pressure modulator in the impaired TM of glaucomatous eyes. Using
this patent pending technology, we have demonstrated that EMC is: (i) functional in cultured TM cells, (ii)
successfully transduced in vivo in TM cells; and (iii) effective in lowering the IOP in a mouse model of ocular
hypertension without (i) non-targeted expression (measured by QPCR); (ii) ocular damage (assessed by OCT);
(iii) inflammatory cytokines in plasma (detected by ELISA); or (iv) immune cell response and (v) loss of viability
of targeted cells expressing EMC over long period. EMC is an engineered version of the bacterial stretch-
activated channel, which directly senses tension in the membrane lipid bilayer of cells and in response,
transiently opens its large non-specific pore for trans/paracytosis. At its pressure threshold, EMC can release
fluid from TM cells to be cleared through SC. Additionally, the resulting decrease in cell volume and size will
widen intercellular spaces and facilitate the paracellular flow of aqueous humor. EMC acts as an ideal drainage
valve for TM cells, because it is a relatively small homo-oligomeric channel and does not need any associated
proteins or energy sources to assemble and function. We have identified optimal EMC variant that is activated
at physiologically relevant pressures using pressure clamp. The goal of the proposed research is to further
develop the product based on the self-complementary AAV carried engineered mechanosensitive EMC
channel (scEMC) for gene therapy of POAG. The objective of this phase-II SBIR project will be accomplished
through three specific aims. Aim 1: Quantify long-term stability of scEMC and safety of scEMC in wild type rats;
Aim 2: Evaluate scEMC-enabled long-term IOP lowering Efficacy in rodent models of POAG and Aim 3: GLP
Study of toxicity and Biodistribution of intracamerally-injected scEMC in wild-type NHPs. The development of a
safe effective single-dose long-lasting treatment for glaucoma via the success of this proposal would improve
the lives of many Americans.

Public health relevance
Vision loss due to glaucoma is the second leading cause of blindness in America, and the currently available pharmacological and surgical treatments for glaucoma have significant limitations and side-effects. Using our patent pending EMC (Engineered Mechanosensitive Channel) technology, we demonstrated that EMC is reliably lowering the intraocular pressure (IOP) in a mouse model of glaucoma, and therefore, we aim to commercialize EMC for gene therapy of glaucoma. The development of a safe effective long-lasting single dose therapeutic for the treatment of Primary Open Angle Glaucoma (POAG) would be transformative in clinical ophthalmology and would improve the lives of millions of people worldwide.